Hazardous Materials Worker Health and Safety Training

Overall Project Summary/Abstract
As a not-for-profit institution created for the sole purpose of improving working conditions in the U.S. construction industry, CPWR’s mission aligns with the goals of the NIEHS Worker Training Program (WTP). CPWR’s purpose as an organization, as stated in its Articles of Incorporation are; “to encourage the elimination or reduction of conditions constituting hazards to the health or safety of workers, and to promote the maintenance and improvement of safe and healthy working conditions for workers.”
Beyond these broad, long-term objectives, the specific aims of this proposed training program are to:
Train 7,851 students in 606 courses in the first year with equal goals over the five- year period, and to continue instructor development through annual Train-the-Trainer programs and Instructor Enhancements (HWWTP);
Train 191 underemployed/unemployed workers in Year 1 in five cities (New Orleans, LA; Flint, MI; Boston, MA; Oakland, CA; and East Palo Alto, CA) and place at least 80% in construction union apprenticeship training programs for jobs in the construction and environmental remediation industries (EWCTP);
Train 1,304 Outreach Trainers and 336 students in disaster related training programs over the five- year period and to continue supporting our current cadre of 3,700 Outreach Trainers on delivering such trainings through-out the country (HDPTP);
Continue rigorous evaluation over the five- year period to continuously assess training effectiveness of all three programs.
To achieve these aims, CPWR submits this application in coordination and cooperation with a training consortium of 13 international/national building trades unions representing workers engaged in hazardous waste work at designated 1910.120 sites around the country, emergency response whether it be natural or man-made, and in other environmentally hazardous work assignments. Our proposed program is therefore national in scope, with our building trades union training consortium representing more than 3 million construction workers geographically dispersed throughout every state in the country.
CPWR’s building trades union training consortium is varied, with each of our 13 partnering unions representing workers that apply different skills necessary on environment remediation sites and during a disaster response. Typical of the cyclical, transient nature of the industry and its workforce, our target population of workers move on and off environmental remediation sites, often moving from one employer to another. The HWWTP proposal in this application describes in detail the types of jobs workers represented by each of our 13 consortium partners perform on designated 1910.120 sites. Whether they work on these sites for years, months, weeks, or just a few days, with the support of this proposed program CPWR and its 13 consortium partners aim to assure these workers are adequately trained to protect themselves, their co-workers, and the environment

Public health relevance
Project Narrative In this application we propose to mitigate the hazards posed by hazardous waste and other hazardous material releases to the environment and public by training the construction workforce to perform clean-up and emergency response operations in a safe and productive manner. A well-trained construction workforce support federal, state, and local government agencies in their efforts to protect the environment and public from hazardous waste and materials, and to respond to disasters whether they are man-made or natural.